Metabolic Studies of Mouse Models of Obesity and Diabetes

The following projects have been supported by Mouse Metabolism Core Laboratory in FY 2014 1. DK031131 Role of muscarinic acetylcholine receptors in glucose and energy homeostasis Principal Investigator: Jurgen Wess (LBC, NIDDK) 2. DK043313 Role of the Gnas Gene in Metabolic Regulation Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 3. DK043315 Role of Gs-alpha in central regulation of energy and glucose metabolism Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 4. DK043316 Role of Gs-alpha in regulation of adipose tissue growth and function Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 5. DK025102 Erythropoietin receptor and glucose metabolism Principal Investigator: Constance T Noguchi (MCB, NIDDK) 6. DK075004 Identification of novel molecules and pathways that modulate adipogenesis Principal Investigator: Elisabetta Mueller (GDDB, NIDDK) 7. DK075003 Regulation of PPARgamma expression and adipogenesis by PTIP-associated factors Principal Investigator: Kai Ge (NRB, NIDDK) 8. DK075017 Epigenetic regulation of adipogenesis. Principal Investigator: Kai Ge (NRB, NIDDK) 9. DK031116 Development of P2Y receptor ligands Principal Investigator: Kenneth A Jacobson (MR, NIDDK) 10. DK060101 Targeted disruption the enzymes of O-GlcNAc cycling: animal models of disease Principal Investigator: John A Hanover (LCMB, NIDDK) 11. DK075057 DEOB Physiology and Pharmacology of BRS-3 (Bombesin Receptor Subtype-3) Principal Investigator: Marc L. Reitman (DEOB, NIDDK) 12. DK075063 DEOB What can body temperature tell us about energy homeostasis? Principal Investigator: Mark L. Reitman (DEOB, NIDDK) 13. DK075064 DEOB Role of brown adipose tissue (BAT) in energy balance Principal Investigator: Mark L. Reitman (DEOB, NIDDK) 14. DK061000 LGP Genetic Approaches to Understanding Organ Development and Function Principal Investigator: Lothar Hennighausen (LGP, NIDDK) 15. DK056018-06 (2012) Sphingolipid Biology and Regulation of Metabolism Principal Investigator: Richard L Proia (GDDB, NIDDK) 16. DK056014 Mouse Models of Novel Sphingolipid Biology and Disease Principal Investigator: Richard L Proia (GDDB, NIDDK) 17. DK036150 Organization and regulation of the human insulin locus Principal Investigator: Gary Felsenfeld (LMB, NIDDK) 18. DK075035 Genes associated with endocrine tumorigenesis Principal Investigator: Sunita K Agarwal (MDB, NIDDK) 19. DK055106 Transforming growth factor - beta superfamily signaling in diabetes and obesity Principal Investigator: Sushil Rane (DB, NIDDK) 20. DK055107 Cell cycle regulators in diabetes and obesity Principal Investigator: Sushil Rane (DB, NIDDK) 21. BC005708 Xenobiotic receptors Principal Investigator: Frank J Gonzalez (LM, NCI) 22. HD000641 Physiology, psychology, and genetics of obesity Principal Investigator: Jack Adam Yanovski (UGO, NICHD) 23. HD000642 Molecular Genetics of Adrenocortical Tumors And Related Disorders Principal Investigator: Constantine A Stratakis (PDEG, NICHD)